Revolutionizing CAR T-cell Therapy: Enhancing Activity and Persistence of CAR T-cell by Developing a CAR-Enhancer Platform

Project Summary
Chimeric Antigen Receptor (CAR) T-cell therapy has achieved notable success in treating various blood-borne
malignancies, with six FDA-approved therapies to date, including four targeting the CD19 protein and two
targeting the B-cell maturation antigen (BCMA). BCMA CAR T-cell therapy has particularly shown promise
against multiple myeloma, even in patients with extramedullary lesions. However, a significant challenge
remains: the durability of response, as most patients experience relapse, correlated with the disappearance of
CAR T-cells from circulation. Enhancing the effector function and persistence of CAR T-cells is crucial to
overcoming these obstacles.
The CAR-Enhancer platform proposes a novel approach to augment the functionality and longevity of CAR T-
cells by promoting the development of memory CAR T-cells. Leveraging a protein-driven mechanism, CAR-
Enhancer obviates the need for specific engineering of CAR T cells, making it universally compatible and
significantly broadening its therapeutic application. With compelling preclinical results, this platform is poised to
revolutionize CAR T-cell therapy, potentially saving lives and advancing the field.
The project’s specific aims are crafted to transition the CAR-Enhancer platform from preclinical development to
clinical application efficiently and effectively. The first aim concentrates on optimizing dosing and timing for
CAR-Enhancer administration in a Phase I clinical trial to enhance post-infusion efficacy. The second aim is to
establish a scalable manufacturing process, ensuring the capability to meet clinical and commercial demands.
The third aim assesses the pharmacokinetics and toxicity profile of CAR-Enhancer in both immunocompetent
mice and non-human primates, providing critical safety data for regulatory approval. This initiative aims to
expand the reach of CAR T-cell therapies, fostering improved outcomes for a wider range of patients with
blood cancers.

Public health relevance
Project Narrative Chimeric Antigen Receptor (CAR) T-cell therapy has transformed the treatment of blood-borne malignancies, yet the duration of response remains a challenge. Our developed CAR-Enhancer protein therapeutic aims to address this issue by enhancing CAR T-cell activity and persistence post-infusion, offering potential as an off- the-shelf treatment. This application focuses on preparing the CAR-E protein therapy for IND-enabling studies and paving the way for clinical translation of the approach.